Mechanisms of Basal Forebrain Control Over Sensory Processing

PROJECT SUMMARY
The overarching goals of the parent award are to develop a mechanistic understanding of how neural circuits in
the basal forebrain impact sensory processing. Toward this, the proposed Aims in the parent award test the
hypothesis that effects of attention, arousal, and reward prediction on olfactory processing rely on precisely
timed, cholinergic signaling within the basal forebrain controlling projection output to the olfactory bulb. This
hypothesis is being tested using a combination of viral genetic engineering, transgenic mouse models, in vivo
two-photon imaging, fiber photometry, mouse behavior, and slice electrophysiology. These complex
experimental paradigms have relatively long timelines for generating mice, performing surgeries, recovery,
training, and data collection. Pausing experimentation for maternity leave would not only disrupt ongoing
experiments, but it would seriously impact future experiments requiring the breeding, preparation, and training
of mice. This supplement proposal seeks to avoid a significant disruption in continuity during the maternity leave
of the parent award PI by providing for (1) a part-time technician for nine months and (2) data storage server
hardware allowing secure, remote access and collaboration across multiple users. The role of the technician will
first be to maintain ongoing mouse experimentation as the PI is fully on leave. Then, as the PI returns from leave
part time, the role of the technician will shift to a combination of maintaining experiments, processing data, and
preparing mice for future slice electrophysiology experiments. Finally, as the PI returns to work full time the role
of the technician will be to maintain the continuity of behavioral experimentation in the case that flexible
scheduling is required on the part of the PI due to the unpredictable nature of childcare. At the same time,
implementing a remotely accessible data storage server will enable real time collaboration between the
technician and the PI for the duration of leave and after returning to work full time. Together these resources will
help maximize productivity and promote continuity of the parent award during the maternity leave of the parent
award PI.

Public health relevance
PROJECT NARRATIVE The overarching goal of this research is to develop a mechanistic understanding of how basal forebrain circuits influence sensory processing, potentially revealing common mechanisms that underlie sensory and cognitive deficits in neurodegenerative disease. This supplement will support the hiring of a part-time research technician to maintain ongoing mouse experiments during the maternity leave of the parent award PI and prepare animals and reagents for the return from leave. Additional support for a remotely-accessible data storage server will allow coordination of data processing and analysis across multiple users on and off campus, enabling progress towards the goals of the parent award while the PI is on leave and returning to work.